Integrative Approaches for Probing Cell Mechanotransduction in Health and Disease

PROJECT SUMMARY
Notch receptors are mechanically activated transmembrane proteins that regulate cell fate, differentiation,
proliferation, adhesion, and many other critical processes. Most studies to date have focused on understanding
Notch from biochemical and genetic perspectives and have only recently been explored as a mechanoreceptor.
Given Notch's varied roles in both standard and pathological states, it is necessary to formulate an integrated
mechano-chemical perspective of Notch signaling and regulation, as such an outlook for a comprehensive
understanding of this critical and evolutionarily conserved signaling pathway. In this project, my lab will leverage
our expertise in chemical probe development and molecular tool design to address sharply focused mechanistic
questions regarding Notch mechanotransduction. To distinguish our contributions from those of others, we will
pursue a multi-scale understanding of the pathway by combining single molecule studies and high-resolution
imaging to understand how the activation of the receptor is coupled to biomechanical events that occur within
the cell. In particular, new correlative light and electron microscopy will be developed and applied to determine
the precise timing and location of events surrounding Notch signal transduction. In addition, to address important
questions regarding the source and magnitude of the external forces experienced by cells, we will also create
synthetic versions of Notch and apply them as genetically encoded “tensiometers.” Successful execution of this
work will provide deep insights into the synergy between biochemical and mechanical cues and increase our
overall understanding of how cells sense and interpret mechanical information.

Public health relevance
PROJECT SUMMARY Notch receptors are mechanically activated transmembrane proteins that regulate diverse physiological processes starting from the earliest development stages and continuing throughout adolescence and adulthood. Examples of Notch-regulated processes range from control of muscle and brain development to coordinating the weekly renewal of cells that form the protective inner lining of the small intestines. Most of what we know about how Notch’s roles in these processes have been gleaned from biochemical and genetic analyses of the receptor's function and regulation. In this project, we will leverage our expertise in molecular tool development to create new tools to investigate the underlying mechanochemical aspects of Notch as a protein and signaling pathway. To distinguish our contributions from those of others and to enable us to make unique discoveries, we will apply an approach that integrates new high-resolution imaging tools with synthetic biology and cell engineering. We will combine these tools to address sharply focused mechanistic questions regarding Notch and how forces are delivered to Notch by ligand proteins to under the biophysical basis of how these forces influence natural and synthetic Notch (synNotch) proteins. The tools developed during the project should proudly apply to mechanically regulated information transfer events beyond Notch signaling, including those involving integrins, adhesion molecules, and immune cell antigen receptors. In particular, new correlative light and electron microscopy will be developed and applied to determine the precise timing and location of events surrounding Notch signal transduction. In addition, to address important questions regarding the source and magnitude of the external forces experienced by cells, we will also create synthetic versions of Notch and apply them as genetically encoded “tensiometers.” Successful execution of this work will provide deep insights into the synergy that exists between biochemical and mechanically-based cues. The work will deepen our understanding of how cells communicate with one another at cell-cell contacts. Information transfer at such sites is crucial to countless physiological processes, and the mechanochemical aspects of such transfer of these events represent a harnessable and untapped aspect of physiology that could potentially be harnessed for the development of new therapeutic strategies.